BOUNCE: Development of a trauma-informed mHealth + peer support intervention to promote PrEP uptake among men who have sex with men

PROJECT SUMMARY
HIV pre-exposure prophylaxis (PrEP) uptake has progressed slowly for men who have sex with men (MSM) in the United States, a population disproportionately burdened by HIV. Addressing trauma and related sequelae such as PTSD may help optimize PrEP uptake in this population, as MSM are disproportionately exposed to trauma, particularly interpersonal violence, much of which is motivated by prejudice. Interpersonal violence carries the highest conditional risk of any trauma exposure for developing posttraumatic stress disorder (PTSD), risk which is further amplified in the case of prejudice-motivated violence. There is limited but compelling evidence to suggest that violent trauma exposure and PTSD symptomology may negatively affect PrEP uptake. However, research with large MSM-only samples that examines these pathways longitudinally is lacking, as are trauma-informed PrEP interventions for MSM.
This K01 will provide the candidate, Dr. John Mark Wiginton, with the expertise, skills, and opportunities necessary to examine prejudice-motivated interpersonal violence and PrEP uptake pathways among MSM using latent class mediation (Research Aim 1); apply these findings, along with qualitative data from community-engaged research with local MSM and stakeholders, toward development of a novel trauma-informed mHealth + peer support intervention (called BOUNCE) targeting PrEP and coping self-efficacy, peer/social support, and resilience factors (safety, autonomy, trust, trauma awareness) to support PrEP uptake among MSM (Research Aim 2); and conduct usability testing and a proof-of-concept pilot of BOUNCE to assess feasibility, acceptability, and PrEP uptake.
Dr. Wiginton will utilize JHU’s training infrastructure to build his professional independence and further cultivate his competence to develop and test trauma-informed HIV prevention interventions tailored to MSM populations to improve HIV disparities and broader sexual health and psychosocial wellness in these populations. Dr. Wiginton seeks training to build his topical and theoretical expertise in trauma exposure, PTSD symptomology, and health behavior impacts (Training Aim 1); gain knowledge and experience conducting community-engaged research (Training Aim 2); develop expertise in designing and delivering interventions (Training Aim 3); build competence in early-phase clinical trial methods and approaches to evaluate behavioral interventions (Training Aim 4); and foster personal and professional development skills (Training Aim 5). With this award, Dr. Wiginton will gain not only exceptional training, but also valuable data, from which to build his research independence with a competitive future R01 to test BOUNCE more rigorously in a Type 1 Hybrid Trial.

Public health relevance
Men who have sex with men (MSM) in the United States shoulder a disproportionate burden of HIV, trauma exposure (especially interpersonal violence that is often motived by prejudice), and associated PTSD symptomology, which may negatively impact uptake of HIV pre-exposure prophylaxis (PrEP), an effective HIV-preventive biomedical intervention. Latent class mediation analysis can identify the extent to which distinct and unique patterns of PTSD symptomology mediate the effect of prejudice-motivated violence on PrEP uptake in this population, and in conjunction with qualitative findings from local violence-exposed MSM and key community stakeholders can inform a novel trauma-informed mHealth + peer support intervention to support PrEP uptake, contributing to a reduction in HIV transmission and related disparities. Through this K01, Dr. Wiginton will leverage the JHU training infrastructure to build his professional research independence for improving PrEP uptake among MSM populations through innovative trauma-informed approaches, positioning him as a leader in the next generation of scholars to contribute toward ending the HIV epidemic among MSM in the United States.